Risk factors associated with the prevalence of Peri-Implantitis disease

This proposal aims to establish a prevalence for peri-implant disease in different regions of the United States along with identifying different risk factors that may increase the incidence and progression of this disease. Peri-implantitis is defined as mucosal inflammation and deep pocket depths surrounding the implant along with 2 mm or more of bone loss after restoration (implant loading), whereas peri-mucositis consists of mucosal inflammation without the bone loss. As more and more implant supported restorations are placed as a therapy for partial or complete edentulism, the incidence of this disease is on the rise. Therefore, developing a model for collective risk factors associated with peri-implantitis is imperative in preventing loss of implants and the restorations they support. The objective of this research project is to determine prevalence of the disease in private dental settings, etiologic bacteria, patient-specific factors, implant characteristics and prosthetic designs which may contribute to the occurrence of peri-implantitis disease. The long-term goal of this research is to develop preventive and specific patient-tailored treatment strategies for early diagnosis and to control progression of peri-implantitis. We will test the central hypothesis that there are unique etiologic bacteria, patient specific, local and material-related factors which influence the occurrence of peri-implant diseases. In order to achieve this goal, we will evaluate peri-implant and periodontal microbiota and local and environmental factors in individuals with and without peri-implant disease. This study plans to utilize the National Dental PBRN, thereby making this study unique, comprehensive and the largest research on analysis of prevalence and etiology of peri-implant disease. We plan to recruit 1000 participants who have had their implants placed and restored for at least 60 months. The dental PBRN practitioners will conduct a thorough dental, periodontal and radiographic exam to determine the periodontal and peri-implant status of the participants. Through plaque and saliva samples collected, we plan to determine differences in the microbiome environment between peri-implant and periodontal health and disease. We propose the following specific aims to test our central hypothesis: Aim 1: To determine the prevalence of peri-implantitis in different regions of the United States; Aim 2: To test the hypotheses that there are specific bacterial species and specific inflammatory markers associated with peri-implant disease; Aim 3: To test the hypothesis that local risk factors are associated with an increased susceptibility to peri-implant disease development such as: a) the presence of Ti and other metallic ions locally; (b) cement retained implant supported prosthetic restorations; (c) the presence of metallic alloys (amalgam, gold or nickel) in the oral environment which could precipitate a galvanic reaction; Aim 4: To develop a model for patient related risk factors associated with susceptibility to peri-implant disease to include: (a) severity of periodontal disease; (b) plaque control and implant maintenance; (c) frequency and duration of smoking habit and; (d) HbA1C levels in diabetes.

Public health relevance
The proposed study entitled “Risk factors associated with the prevalence of peri-implantitis disease” is a study on how often peri-implantitis occurs in a dental private practice setting and what are the different risk factors that contribute to this disease. This is very important to public health because the study will allow us to discover why and how people with dental implants get this disease which leads to gum inflammation, bone loss and eventually loss of the implant. This will allow the patient or the dental consumer to protect his investment by paying for a product that will have a more predictable success rate and will have minimal failure in the future.